INTERCEPT

Project Summary/abstract
Tuberculous meningitis (TBM) disproportionally affects small children, and immunopathology likely contributes
to its high mortality and physical and cognitive morbidity. Recent unbiased cross-omics studies have identified
biological pathways involved in the outcome of TBM in adults that could help development of more effective host-
directed therapy for TBM, but it is unknown if similar or other pathways are implicated in childhood TBM.
We previously identified high levels of cerebrospinal fluid (CSF) tryptophan, a nutrient for Mycobacterium
tuberculosis, and genetic traits that predict CSF tryptophan concentrations as strong markers for mortality of
TBM. By integrating large-scale clinical, metabolomics and genomics data we have strengthened these findings
and identified additional metabolic pathways implicated in outcome of TBM in adult patients. Separately, we
found that CSF levels of matrix metalloproteinases (MMP-10), as well as genetic traits associated with CSF
MMP-10 levels, also predict mortality of adult TBM patients. This suggests that metalloproteinases may also be
implicated in TBM outcome, possibly through blood-brain barrier dysfunction resulting in cerebral edema and
influx of inflammatory cells. These findings raise the question if these biological pathways are also involved in
the immunopathology and poor outcome of pediatric TBM. Lastly, we recently showed that adjunctive aspirin
might reduce brain infarctions and death from TBM in adults. Therefore, we are conducting a separately funded
phase 3 clinical trial of aspirin in children with TBM to determine if it reduces mortality and long-term disability.
Therefore, based on our previous work we hypothesize that: specific metabolic pathways including tryptophan
metabolism influence outcome of pediatric TBM, and that this is genetically regulated (Aim 1);
metalloproteinases are implicated in the immunopathology and outcome of TBM (Aim 2); and integration of
large-scale clinical and ‘omics’ data and comparison of pediatric and adult TBM patients can predict the
therapeutic effect of aspirin, and identify novel targets for host-directed therapy of pediatric TBM (Aim 3). To test
these hypotheses, we will combine unique access to some of the largest clinical studies in TBM globally with
exceptional expertise in integration of multi-omics and deep-phenotyping data.
Our strong preliminary data, access to two large bioarchives from adult TBM, an on-going randomized controlled
trial in pediatric TBM, and expertise in integration of large-scale clinical and multi-layer ‘omics’ data promises to
provide a step-change in understanding childhood TBM pathogenesis and discovery of new targets for future
host-directed therapies.

Public health relevance
Project Narrative Tuberculous meningitis (TBM) disproportionally affects young children as the most lethal form of tuberculosis. INTERCEPT aims to better understand the biological pathways that determine death or survival from TBM, both in children and adults, and how they might be manipulated therapeutically with better-directed or novel host directed therapeutic strategies.